Regulation of Adherent Cell Proliferation by Matrix Viscoelasticity

Cell proliferation is a fundamental biological process that often occurs for cells in a 3D context in vivo, in which
cells are surrounded by extracellular matrix (ECM) and other cells, and various applications rely on the
proliferation of cells within a biomaterial. It has long been known that changes in matrix stiffness impact cell
behaviors through mechanotransduction, and mechanisms of stiffness-sensing in 2D culture are now
established. However, the mechanisms mediating the impact of changes in matrix stiffness on cell proliferation
in 3D remain unclear. Further, living tissues and ECMs are viscoelastic, exhibiting some characteristics of elastic
solids and some of viscous liquids. Matrix viscoelasticity is sensed through mechanotransduction, and we have
found that changes in matrix viscoelasticity impact cell spreading, migration, proliferation, stem cell
differentiation, matrix deposition, morphogenesis, and gene expression. However, the mechanisms mediating
the impact of matrix viscoelasticity on these processes, particularly proliferation remain unclear. The goal of the
proposed work is to determine the mechanism mediating the impact of matrix stiffness and viscoelasticity on cell
proliferation in 3D matrices. Our overall hypothesis is that mechanosensitive ion channel-mediated pathways
and integrin-mediated pathways interplay to sense matrix viscoelasticity and stiffness, and subsequently control
proliferation through changes in chromatin accessibility, YAP-independent transcription, and a set of molecular
regulators not implicated from 2D culture studies. We will address this hypothesis in 3 aims, using an approach
that involves the use of alginate hydrogels with independently tunable viscoelasticity, stiffness, and RGD ligand
density for 3D culture of adherent cells, including fibroblasts, epithelial cells, and mesenchymal stem cells. In
aim 1, we will determine the biophysical mechanisms underlying the impact of hydrogel viscoelasticity, stiffness,
and adhesivity on the proliferation of adherent cells in 3D culture. In Aim 2, we will elucidate transcriptional and
epigenetic regulation of mechanotransduction and proliferation, using RNA-seq and ATAC-seq combined with
advanced bioinformatics analyses. In Aim 3, we will identify novel regulators of proliferation and
mechanotransduction in 3D using genome-wide CRISPR screening. Innovative aspects of this approach include
the study of mechanisms mediating mechanotrasduction and proliferation in 3D matrices, the focus on
viscoelasticity (beyond stiffness), the potential for discovering YAP-independent mechanisms of
mechanotransduction, the identification of how the epigenome regulates mechanotransduction and proliferation
in 3D, and the application of a CRISPR screen to identify novel molecular regulators of mechanotransduction.
The significance of this work is that it will determine the biophysical and molecular mechanisms by which ECM
or biomaterial stiffness and viscoelasticity regulate cell proliferation in 3D. Given the importance of cell
proliferation, the ubiquity of matrix viscoelasticity in ECMs, and the potential relevance of discovered
mechanisms of mechanotransduction to other processes, the significance is expected to be high.

Public health relevance
Project Narrative Extracellular matrix stiffness and viscoelasticity regulates cell proliferation in 3D microenvironments through mechanotransduction, but the mechanisms mediating these effects remain largely unclear. Here we will combine biophysical approaches with genome-wide analyses and CRISPR screens to determine the mechanisms mediating the impact of matrix stiffness and viscoelasticity on cell proliferation. Therefore, the proposed research is relevant to the part of NIH’s mission that seeks to develop fundamental knowledge that will help reduce the burdens of human disability and disease.